A Randomized Clinical Trial Comparing Brief and Standard Cognitive-Behavioral Therapies for Insomnia in Veterans

Veterans seen in VA primary care and mental health clinics commonly present with complaints of sleep
disturbance, especially insomnia. For example, in a cross-sectional study examining sleep disorders among
Veterans seeking care through the Veterans Health Administration between 2000-2010, sleep apnea (47%) and
insomnia (26%) were the most commonly diagnosed conditions. In a study of 375 Operation Enduring
Freedom/Operation Iraqi Freedom Veterans, 45% reported extended time spent trying to fall asleep (> 30
minutes), 21% reported reduced total sleep times (< 4.5 hours), and 56% reported being awake in bed more
than 15% of the night. Similarly, in another observational study of 5,552 Veterans, 57.2% of the sample
population was found to have insomnia disorder. This sample also was at high-risk for a host of clinical disorders,
including PTSD, TBI, and pain; all of which showed higher rates of insomnia.
Cognitive Behavioral Therapy for Insomnia (CBT-I) is a multi-component intervention that features sleep
restriction, stimulus control, sleep hygiene education, cognitive therapy, and can include relaxation techniques.
CBT-I is recognized as the first-line treatment for chronic insomnia and is effective in Veterans, however,
limitations to use still remain. In recent years advances in treatment approaches have attempted to streamline
CBT-I by focusing on delivery of specific treatment components, reducing number of treatment sessions, and/or
use of technologies that provide for ease of dissemination and implementation. Brief Cognitive-Behavioral
Therapy for Insomnia (bCBT-I) represents one such empirically tested brief intervention which may decrease
patient burden through reduced sessions needed to achieve treatment goals and through use of hybrid treatment
administration (i.e., in-person and telemedicine).
To better inform both clinical practice and future research, this investigation proposes to assess the comparative
effectiveness of bCBT-I to VA standard CBT-, with several overarching goals: 1) in a randomized clinical trial
(RCT), evaluate the equivalence (non-inferiority) of bCBT-I to VA standard CBT-I; 2) evaluate the impact of these
treatment approaches on functional rehabilitation outcomes; 3) evaluate the impact of these treatment
approaches on psychiatric symptomatology; and 4) in an exploratory fashion, determine which patient factors
best predict success or failure with a given treatment as a means of developing insomnia phenotypes that might
be used diagnostically to match patient characteristics and type of treatment to help optimize clinical outcomes
(i.e., a “personalized medicine” approach to treatment).
The investigation timeline consists of four parts: 1) baseline assessment of sleep, functional, and psychiatric
outcome measures; 2) randomization and assignment to either CBT-I or bCBT-I; 3) post-treatment assessment;
and 4) 3-month follow-up assessment. Over 40 months of recruitment this study will enroll and randomize 180
Veterans on a 1:1 ratio (CBT-I:bCBT-I= 90:90) from VA primary care and mental health clinics at two Centers of
Excellence sites (VA San Diego Healthcare System and Finger Lakes VAMC Healthcare System). For the
primary study aim, one-sided mean difference testing will be conducted with the noninferiority margin added to
the null value. Secondary analyses will utilize structural equation modeling to evaluate how CBT-I and bCBT-I
influence functional and psychosocial outcomes. The Exploratory aim will utilize moderation analyses to better
understand for whom either CBT-I and/or bCBT-I might be more effective.

Public health relevance
Insomnia is a common condition in Veterans, with prevalence rates as high as 53% among treatment-seeking Veterans. Chronic untreated insomnia is associated with increased risk for functional impairment, psychiatric illness, suicidal ideation, unhealthy lifestyles, and decreased quality of life. Cognitive-Behavioral Therapy for Insomnia (CBT-I) is recognized as the first-line treatment for insomnia. Despite its proven efficacy, CBT-I is not always readily provided and/or accessible to Veterans. To address these limitations, behavioral sleep medicine specialists have endeavored to streamline CBT-I through development of time-shortened variations of CBT-I. Although these modifications show promise for advancing care and access, studies comparing brief treatments to standard CBT-I have yet to be performed. This investigation will therefore compare a 4-session brief CBT-I to VA standard 6-session CBT-I to evaluate whether a brief intervention can provide comparable benefits to sleep, functional, and psychiatric outcomes in Veterans with insomnia.